Growth and adiposity in newborns: the influence of prenatal DHA supplementation

PROJECT SUMMARY/ABSTRACT
The prevalence of childhood obesity has dramatically increased leading to the prediction of a rapid
generational decline in life expectancy and to a surge in medical care costs. Offspring exposed to excessive
gestational weight gain (GWG) have greater total fat mass (FM) and central adiposity in childhood and are
more likely to be overweight or obese. Currently, 56% of pregnant women experience excessive GWG. In
pregnancies that experience GWG, it is critical to understand factors that influence FM accumulation and direct
adipose tissue (AT) distribution as these are important early drivers of obesity occurrence, disease risk, and
severity of disease development. Polyunsaturated fatty acids (PUFA) influence adipocyte development and FM
accrual in two ways: influencing cell differentiation and fatty acid metabolism regulation. Increased prenatal
exposure to the n-3 fatty acid family, including docosahexaenoic acid (DHA), prevented adipocyte maturation
and suppressed genes involved in lipogenesis and increased the expression of genes involved with β
oxidation. The overall net effect was a decrease in AT deposition. Observational studies associate greater
maternal DHA levels with lower offspring FM, visceral AT and greater fat-free mass in childhood. However,
data are lacking from RCT studying a contemporary U.S. based cohort where DHA is prenatally supplemented
and offspring fat accrual and distribution are directly measured. This study will take advantage of an ongoing
Phase III randomized, double blinded, and placebo controlled U.S. based pregnancy cohort (R01 HD083292,
ClinicalTrials.gov ID: NCT02626299) in which n=400 women will be randomized to either 1000 mg/day or 200
mg/day of DHA during pregnancy. The purpose of the follow-up study is to determine how the prenatal dose of
DHA interacts with GWG to influence offspring FM accrual. Data are lacking that examine important
moderators and potential therapeutic targets that influence offspring growth and body composition changes
during a critical period of the first 1,000 days suggested to be significant for programming the offspring
phenotype. To develop effective interventions, it is important to understand nutrients that may protect against
an offspring phenotype related to metabolic disease risk. Observational evidence in humans and basic animal
research suggest that DHA, a nutrient generally low in the diet of US women, could be such a nutrient. This
project is innovative, capitalizing on a large, ongoing, RCT of high and low-dose DHA supplementation of U.S.
pregnant women, testing the efficacy of DHA supplementation in women with excessive GWG, and using direct
measures of body composition (DXA). This data will inform the gap in knowledge regarding the impact of high
levels of prenatal DHA supplementation on programming offspring FM accrual. The proposal will help identify
the need for new recommendations for prenatal DHA supplementation by our National Academy of Medicine
(DHA is not recognized in the US as an essential nutrient) and lead to evidence-based guidelines for DHA
supplementation during pregnancy where none currently exist.

Public health relevance
Project Narrative Excessive gestational weight gain (GWG), experienced in 56% of pregnancies, is related to increased offspring total and central adiposity and disease risk. We will test if high dose prenatal DHA supplementation prevents excess offspring fat accretion and programs a favorable adipose tissue distribution.